IDeA Networks of Biomedical Research Excellence in Kentucky

Overall Summary
The overarching goal of the Kentucky Institutional Development Award (IDeA) Network of
Biomedical Research Excellence (KY-INBRE) is to build capacity for health-related and
biomedical research in the Commonwealth of Kentucky. We will build a collaborative research
and research-training community throughout the state. Our primary collaborative network is
represented by 2 research intensive universities, 5 state-supported and one independent,
primarily undergraduate institutions (PUIs). We provide outreach activities in support of many
other of our smaller state supported and independent institutions including community technical
colleges. Overall, our activities are designed to build on our established multi-disciplinary research
network, with a focus on functional genomics, as a means to strengthen research infrastructure
of the lead and partner institutions. One aim is to support the development of young research
faculty investigators to help them become independently competitive for federal research grants.
Another aim of our network is to provide a variety of research training opportunities for our
undergraduate and graduate students. These students represent the next generation of the health
care and/or biomedical research industries and they need to be mentored to develop appropriate
scientific research skills.
.

Public health relevance
OVERALL Project Narrative: The health relatedness of this project lies with its goal to build capacity for health and biomedical research throughout the Commonwealth of Kentucky. Moreover, one of its primary concerns is to train the next generation of workers in the health care and biomedical research industries in Kentucky